Addressing the Training Gap in Oncology on Sexual Health: Development of the Sexual Health Integrative Fellowship Training (SHIFT) Course for Hematology-Oncology Fellows

PROJECT SUMMARY
Over half of patients treated for cancer report concerns related to sexual health. If unaddressed, such concerns
can cause substantial distress and compromise patients’ health and overall well-being. Although clinical
guidelines uniformly recommend oncologists discuss sexual health with their patients, evidence suggests that
sexual health is overwhelmingly neglected in patients’ routine cancer care. Oncologists lack knowledge and skills
with which to effectively discuss sexual health, largely because most have received no relevant training. A recent
survey of hematology-oncology fellowship programs in the U.S. by our team found that the majority offer little to
no formal training in sexual health. The failure to educate hematology-oncology fellows on sexual health in the
face of prevalent cancer-related sexual problems and considerable patient distress constitutes a critical gap in
preparedness of the oncology workforce in the U.S. A training course for fellows on addressing cancer-related
sexual health is likely to be both highly acceptable and impactful because it would (a) fit well into the educational
setting of the fellowship program and (b) provide the foundation for clinicians-in-training to develop effective
clinical practice patterns that integrate regular communication about cancer-related sexual health. Therefore, we
propose to develop a novel virtual course, called Sexual Health Integrative Fellowship Training (SHIFT), that (a)
will provide education and skills training in communication about cancer-related sexual health to hematology-
oncology fellows and (b) is guided by theory, significant preliminary qualitative and intervention research by the
project team, and active involvement from a diverse Patient Advisory Board and other key stakeholders. Because
certain cancer patient subgroups (e.g., sexual and gender minority patients) may have unique cancer-related
sexual concerns and communication needs, SHIFT will include content to facilitate fellows’ effective
communication about sexual health with a diverse patient population. Aim 1 of the project is to develop the SHIFT
course, which we expect will improve hematology-oncology fellows’ knowledge, beliefs based in social cognitive
theory (i.e., self-efficacy and outcome expectancies for sexual health communication), and clinical
communication outcomes (i.e., comfort and communication about sexual health). Aim 2 is to evaluate the
acceptability and impact of SHIFT on knowledge, beliefs, and sexual health communication among two cohorts
of hematology-oncology fellows from Fox Chase Cancer Center (primary site) and Dana-Farber Cancer Institute.
We will then refine the course and plan for its dissemination. The proposed study will be the first to develop and
test a training course designed to equip fellows in oncology to address sexual health with their cancer patients.
This study represents a logical next step in an ongoing body of research centering on the development of
evidence-based interventions to improve patient-clinician communication about sexual health in cancer. The
overarching goal of this line of work is to improve the health and quality of life for patients with cancer through
integrating effective clinical communication about sexual health into their routine cancer care.

Public health relevance
PROJECT NARRATIVE Although clinical guidelines recommend that sexual health be routinely discussed clinically for all patients with a cancer diagnosis, a lack of training for oncologists in how to discuss sexual health effectively with patients serves as perhaps the single most critical impediment to clinical communication about this topic. The objectives of the proposed project are to (1) develop a novel, virtual group-based course to train fellows in hematology-oncology in effective clinical communication about sexual health (SHIFT; Sexual Health Integrative Fellowship Training), and (2) evaluate the acceptability and impact of the course across two fellowship programs. This project has public health relevance because enhancing hematology-oncology fellows’ communication skills about sexual health with their patients could enhance delivery of cancer care and improve outcomes for patients’ sexual health and overall quality of life.